Core A - Administrative Core

CORE SUMMARY
The Administrative Core (Core A) is an essential core that will coordinate and provide appropriate
administrative support for all three Projects and three other Cores in the Inhibitory Receptor-PPG (IR-
PPG). The Core will provide administrative support for the PI of this Core and the IR-PPG (Dr. Dario Vignali) and
will be located at the University of Pittsburgh School of Medicine, Pittsburgh, USA.
This core will establish a centralized and transparent organizational structure to coordinate all scientific aspects
of the IR-PPG and resolve any conflicts or issues. This core will pursue two aims in support of the IR-PPG:
AIM 1: To provide collaborative and educational support for the IR-PPG. Core A will continue to support
and promote collaborative and educational efforts, data sharing, and synergy by performing the following five
key tasks: (1) Maintain OneDrive account, (2) Organize monthly meetings, (3) Coordinate biostatistical support
and promote rigor; (4) Promote education and training, and (5) Coordinate annual IR-PPG retreat and External
Advisory Committee (EAC).
AIM 2: To provide administrative support for the IR-PPG. Administrative support and coordination will be
provided through seven key tasks: (1) Monitor progress on Projects and use of Cores, (2) Prepare non-
competitive renewal applications/progress reports, (3) Provide budgetary management and fiscal, regulatory,
and compliance oversight, (4) Coordinate data management and resource sharing, (5) Authentication of key
resources, (6) Verification of manuscript submission to PubMed Central, (7) Conflict resolution.
IR-PPG Interactions: Core A works extensively with Projects 1, 2, and 3 to provide administrative and
organizational support, monitor progress, and host data and presentations. Core A also helps coordinate Cores
B, C, and D by providing a platform for data sharing and management, monitoring usage and productivity, and
managing budgetary responsibilities. Lastly, Core A organizes meetings and retreats for all PPG members.